Project 4: Arsenic, Iron, Sulfur and Organic Carbon Speciation and Their Impact

Arsenic groundwater concentrations are determined in part by their sediment concentration but also by sediment mineralogy and the transformations that affect them. The first goal of this project is to examine the spatial distribution of aqueous As (and other analytes) within the comprehensive sampling efforts outlined in Projects 5 (Vineland), 6 (Bangladesh) and Cores to link groundwater As levels to tangible aqueous and sediment properties (e.g., mineralogy, measured using state-of-the-art spectroscopic methods including Fe, As, and S X-ray spectroscopy) and the biological communities that transform them (with 16 rDNA community libraries and functional gene analysis). As part of this comprehensive effort, this project will characterize the Fe, As and S phases that regulate dissolved As concentrations, identify active redox processes in the aquifer that affect these phases and the bacteria that facilitate these processes, and determine which active carbon pools drive microbial respiration. The second overarching goal of this project is to examine the role of transformations in sediment mineralogy and aquifer geochemistry on arsenic levels. Within the simulated pond-village in Araihazar, and the Vineland Superfund Site, we will study the relationship between sediment mineralogy, redox status, microbial populations and arsenic levels, but we will also be able to monitor how those and other parameters change over time in controlled laboratory experiments. These batch and column studies will use natural sediments and will probe the effect of perturbations of geochemical conditions on sediment biogeochemical processes, Fe, S and As mineralogies, and As geochemistry. These manipulations will directly probe the question of the effect of human activity on As contamination (applicable to Proj. 6 goals), and will allow us to examine the rates of relevant and fundamental environmental processes for the first time. The resulting data will then be used to develop and calibrate reactive transport models that more accurately capture the processes that affect As partitioning (Proj. 5, 6, Hydrogeology Core). These data also will be used to engineer improved remediation solutions at the Vineland Superfund site.

Public health relevance
RELEVANCE (See instructions): Arsenic is ubiquitous, yet groundwater concentrations, the principal route of human exposure, are highly variable. An improved understanding of the processes that regulate arsenic levels is needed identify safe and contaminated water supplies and thus minimize the risks of this contamination. Fundamental knowledge of the biogeochemical processes that affect As levels is therefore directly relevant to public health.